Training Program for Quantitative Population Sciences in Cancer

PROJECT SUMMARY/ABSTRACT
Modern biomedical research relies on new approaches to advance our understanding of complex and
multifaceted illnesses of growing public health significance such as cancer. Emerging technologies enable
population scientists to generate data on a scale never before imaginable (i.e., through whole genome array
scans). Thus, there is a critical need to not only train the next generation of scientists in the classic disciplines
involved in studies of human malignancies, but to cross-train them in complementary disciplines to allow them
to bring their scientific discoveries to light. Therefore, we propose to continue a highly successful postdoctoral
program that combines specialized research knowledge and methodologies in the fields of bioinformatics,
biostatistics and epidemiology. This novel program, entitled “Training Program for Quantitative Population
Sciences in Cancer,” is structured to complement the existing resources for cancer research and education at
the Geisel School of Medicine and the Norris Cotton Cancer Center (NCCC), an NCI designated
Comprehensive Cancer Center affiliated with the Geisel School of Medicine at Dartmouth and Dartmouth
Hitchcock Medical Center (DHMC). Our training efforts will continue to be led by investigators with
complementary expertise in the fields of bioinformatics, biostatistics and epidemiology primarily within the
Departments of Biomedical Data Science, Epidemiology and Molecular and Systems Biology. We will
capitalize on Dartmouth’s talented cadre faculty in these disciplines who can offer expert mentorship, and a
versatile portfolio of research and center grants that can supply access to a wealth of population science data,
biologic samples and core research facilities. To accomplish our objectives, we propose to cross-train eight
postdoctoral trainees in epidemiology, bioinformatics or biostatistics for a period of 2 to 3 years. Trainees will
be paired with a primary and secondary mentor from two of the focus disciplines and complete cross-
disciplinary coursework with an optional MS degree in Quantitative Biomedical Sciences. In years two and
three of the program, trainees will concentrate on the conduct of mentored research activities, prepare a mock
NIH grant application, and participate in the preparation of professional manuscripts, presentations at
symposia and scientific conferences and an optional research externship. Program leaders, in consultation
with an Advisory Committee, will select trainees, monitor their progress and provide recommendations to
ensure that the necessary didactic and research experiences are provided to produce highly knowledgeable
investigators for the future of interdisciplinary cancer research in the population sciences. The ultimate goal of
the training program is to accelerate cancer research by enhancing the existing pool of cancer researchers
with the skills to meet the present and future challenges in translational cancer research in the population
sciences.

Public health relevance
PROJECT NARRATIVE/RELEVANCE We will continue our goal of improving the resources available for future cancer research by providing innovative interdisciplinary training for postdoctoral fellows. This program is designed to provide early career researchers with opportunities to integrate specialized research knowledge and methodologies within the fields of bioinformatics, biostatistics and epidemiology. Trainees will be positioned to expedite the translation of cancer science into clinical and public health practice as leaders on multidisciplinary research teams.